Child Health Research Center

DESCRIPTION (provided by applicant): This is a new application (RFA-HD-13-011) for support of the Child Health Research Center at Washington University School of Medicine. Pediatric physician-scientists play a vital role in advancing knowledge related to child health. There is a national need to stimulate child health research by enhancing the training of young pediatric physician-scientists. This program supports the mentored career development of young pediatric physician-scientists by optimally utilizing the resources of the Washington University School of Medicine as we have done for the past 16 years. The long term goal of our Center is to develop Scholars in human developmental biology. We shall achieve this goal by applying the recent advances in basic sciences (developmental biology, cell biology, immunology, genomics, etc.) to an understanding of the pathogenesis of a broad spectrum of diseases within the Pediatric arena. In order to accomplish this, we shall combine the established areas of investigative strength of Washington University School of Medicine and the Department of Pediatrics. Our Scholar's Program, now sixteen years old, will ultimately close the gap between basic scientists and pediatric clinicians. We have in place a programmatic structure in which bright, motivated, young pediatric scientists flourish in a protected environment supported by exceptional mentors and an institutional culture and organization which optimizes their emergence as leaders in an evolving area of Pediatrics. Alan L. Schwartz, Ph.D., M.D. will serve as P.I. /P.D. and Robert Heuckeroth, M.D., Ph.D. will serve as Training Director. The Center (via this award and matched funds from Washington University School of Medicine) and its Scholars will continue to utilize our institutionally-funded core facilities for generation of animal models of human disease states via new and evolving state-of-the-art technologies. The long term goals of the Center will be realized as its Scholars contribute to the development of and leadership in human developmental biology during the next two or more decades.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pediatric physician-scientists play a vital role in advancing knowledge related to child health. There is a national need to stimulate child health research by enhancing the training of young pediatric physician- scientists. This program supports the mentored career development of young pediatric physician-scientists by optimally utilizing the resources of the Washington University School of Medicine as we have done for the past 16 years.